Cocaine use, viral suppression and precursors of stroke in HIV infection

PROJECT SUMMARY/ABSTRACT
Stroke is a major cause of disability and mortality, particularly in low-income individuals and
people living with HIV (PLWH). It is associated with a variety of substances, including
amphetamines, opiates, cannabis, alcohol, tobacco, and especially cocaine. However, most
stroke studies do not account for drug use outside of alcohol or tobacco, and substance use is
not included in stroke risk calculators. Our preliminary data suggest that cocaine use may
influence mechanisms of stroke. If true, the consideration of cocaine use in stroke risk
calculators could greatly improve risk assessment in PLWH who use drugs. We propose a new
study to assess whether cocaine and polydrug use, in combination with inflammation, are
significantly associated with stroke and mechanisms of stroke. The study will be one of very few
to recruit participants from both safety net HIV clinics and community-based settings. It will
provide much needed information regarding factors that influence conditions preceding stroke in
PLWH who use drugs.

Public health relevance
PROJECT NARRATIVE HIV and cocaine use are strongly linked to stroke, but substance use outside of alcohol and tobacco are not included in stroke risk calculators, even those adapted for people living with HIV (PLWH). Whether including the use of cocaine would improve the detection of people at the highest risk for stroke is unknown. We propose a study to determine the simultaneous influences of cocaine, polysubstance use, inflammation and traditional risk factors on stroke and cerebrovascular conditions that directly precede stroke.